Point of Care Technology Research Center in Primary Care - Blueprint Pilot Additional

Project Summary/Abstract
The goal of the NIH Blueprint for Neuroscience Pilot Program is to find, fund, and
facilitate projects in targeted neuroscience research areas, to help move projects
beyond discovery and toward commercialization.
As the Coordinating Center (CC) for POCTRN, and the CC for the POCTRN RADx
Initiative, CIMIT will utilize our award management process to support a POCTRN
solicitation for the NIH Blueprint for Neuroscience Pilot Program projects that hold great
potential for to commercialization of products in this arena.
The CC will create a new section of the POCTRN network website (poctrn.org) that will
be dedicated to opening a solicitation for applications for the NIH Blueprint for
Neuroscience Pilot Program, and will ultimately find, fund, facilitate, and ultimately help
accelerate 7 projects through this program.
The CC will leverage existing relationships between POCTRN and regulatory authorities
to make regulatory input available for project teams and Execs will ensure that teams
utilize well-established quality systems methods in the course of their work.
Many basic science research findings lead to new discoveries years later, but through
the NIH Blueprint for Neuroscience Pilot program, CIMIT aims to bring a more
aggressive approach to accelerate the commercialization of products.

Public health relevance
Project Narrative The goal of the NIH Blueprint for Neuroscience Pilot Program is to find, fund, and facilitate projects in targeted neuroscience research areas, to help move projects beyond discovery and toward commercialization. Many basic science research findings lead to new discoveries years later, but through the NIH Blueprint for Neuroscience Pilot program, CIMIT aims to bring a more aggressive approach to accelerate the commercialization of products. CIMIT’s approach to managing the NIH Blueprint for Neuroscience Pilot Program is to find, fund, facilitate, and ultimately help accelerate 7 projects through this program.